ZINC ABSORPTION AND ENDOGENOUS ZINC LOSSES IN THE NORMAL BREASTFED INFANT

Stable isotope techniques will be used to achieve quantitative determinations of zinc absorption and endogenous losses of zinc in breast-fed infants.